Discovery of a pigment produced by Streptococcus pyogenes

Discovery of a pigment produced by Streptococcus pyogenes
Abstract
This proposal seeks to advance a new observation that the human pathogen Streptococcus pyogenes (Group
A Streptococcus, GAS) produces a pigment that has gone unreported. We hypothesize the pigment protects
GAS from host-derived and/or environmental stressors (such as reactive oxygen species) and likely enhances
its fitness and potentially augments its virulence. For 80 years, no reference in the literature exists of a pigment
being produced by this important organism, and prior to that, only two citations allude to such a factor. We
suspect this property has been overlooked because its presence only becomes apparent in the laboratory after
culturing in a chemically defined medium, grown to high cell densities, and after exposure to oxygen.
Understanding if and how the production of a pigment could boost the fitness of GAS could provide a new
target that therapeutics or vaccines could take aim upon. The objectives of this proposal are to elucidate the
composition and structure of the GAS pigment, to identify genes associated with its production and regulation,
and to characterize its ability to protect GAS from stressors and immune cell killing while exploring any
cytotoxic properties.

Public health relevance
Narrative Pigments produced by bacterial pathogens contribute to the virulence of the microorganism. Here we describe the discovery of and propose to elucidate the composition of an uncharacterized pigment of the human pathogen Streptococcus pyogenes (Group A Streptococcus). It is also our objective to identify genes involved in its biosynthesis and regulation, and how the pigment aids in bacterial fitness or pathogenesis. Our proposed work is likely to advance the understanding of how S. pyogenes survives in the body and may advance efforts to develop a successful vaccine against this pathogen.